Resilience/Resistance to Alzheimer's Disease in Centenarians and Offspring (RADCO)

PROJECT SUMMARY/ABSTRACT
The NIA funded parent project, 1U19AG073172, “Resilience/Resistance to Alzheimer’s Disease in
Centenarians and their Offspring (RADCO)” seeks to characterize cognitive resilience or brain resistance to AD
and to discover the underlying and hopefully translatable biological mechanisms that enable centenarian
cognitive superagers to maintain cognitive function typical of cognitively intact septuagenarians. To address
reviewers’ concerns that African Americans (n=88 or 7.2%) are underrepresented in the RADCO sample and
that too few centenarians (n=75 or 15% of the total neuroimaged sample) undergo neuroimaging, this
administrative supplement application seeks to fund a fourth phenotyping and biospecimen core and
neuroimaging core site at Georgia State University (GSU). The GSU site will enhance the diversity of the
RADCO cohort by enrolling 234 African Americans, thus increasing the proportion of the RADCO sample that
is African American from 7.2% (88/1216) to 22.2% (322/1450). GSU is also able to be a fourth neuroimaging
site for RADCO as it has a Prisma MRI platform and routinely performs the key structural and resting state
functional pulse sequences that are identical to those used by the three current neuroimaging centers of the
Neuroimaging Core as well as the Human Connectome-Aging project. We anticipate that about half (n=103) of
the Atlanta-based participants will undergo neuroimaging. Of these 103 additional neuroimaged participants,
we estimate 44 will be centenarians. These 44 centenarians added to the RADCO-wide sample of 150
centenarians will bring the proportion of centenarians who are neuroimaged to 34% (194/573). Dr. Vonetta
Dotson’s expertise and demonstrated success in engaging the local African American community for
enrollment in research studies provides RADCO with the opportunity to substantially increase our African
American participant enrollment that will provide an adequately powered sample to discern race-specific
differences and similarities in determinants or markers of cognitive superaging. The conduct of this African
American participant enrollment effort at GSU provides the added benefit and rare opportunity to collaborate
with the Georgia State/Georgia Tech Center for Advanced Brain Imaging (CABI), led by Vince Calhoun, to
increase our sample of participants undergoing the rigorously standardized neuroimaging component of the
Study.

Public health relevance
PROJECT NARRATIVE The overarching goal of the parent grant is to characterize cognitive resilience or brain resistance to AD and to discover the underlying and hopefully translatable biological mechanisms that enable centenarian cognitive superagers to maintain cognitive function typical of cognitively intact septuagenarians. This administrative supplement adds Georgia State University as a study site which will markedly enrich the study sample with African American participants and significantly increase the number of centenarians that participate in the neuroimaging component of the study.